Laboratory Sciences Core

Project Summary/Abstract (Laboratory Sciences Core (Core D))
In this 4th renewal application of the Miami CFAR, Drs. Savita Pahwa as Director and Sion Williams as Co-
Director of the Laboratory Sciences Core (Core D) propose a centralized resource for immunology, genomics
and virology with opportunities to stimulate novel HIV/AIDS research towards notable benchmarks of success.
Since its inception, the goal of the Miami CFAR has been to evolve to keep pace with the changing needs of the
epidemic to address important questions in HIV/AIDS. Accordingly, Core D’s strategy has been to maximize
Core resources by leveraging institutional and external resources in order to be at the forefront of HIV/AIDS
research. In the current cycle (2017-2022), Core D has made tremendous progress, energized by new projects,
new technologies and new equipment. We remain cognizant of expectations from the users through periodic
needs assessment exercises, adequate Core utilization to support for projects of our funded research base
(FRB) and pilot awardees, mentorship to students and junior faculty, support research presentations at
conferences and establish linkages with other CFARs to maximize our capabilities for alignment with NIH
research priorities and advances in the field. For the next funding cycle, our goal is to provide needed services
to our investigator base while ensuring access to state-of-the-art technologies that drive innovation and help to
address key scientific questions in HIV/AIDS. Our specific Aims are: Aim 1. Serve as a one stop shop, that
allows investigators to easily access Immunology, Virology and Genomics services to meet both needs for high
demand assays as well as specialized assays that require dedicated expertise. Aim 2. Provide consultation,
training and technical assistance for investigators at all levels (from undergraduate students to established
investigators) to meet their needs for study design, generation of preliminary data and data for publications, and
to disseminate information about scientific advances in the field through special lectures and workshops in
collaboration with the Sylvester Cancer Center, Clinical and Translational Science Institute (CTSI) , and
Departments of Microbiology and Immunology, and Infectious Diseases Division at the University of Miami (UM).
Aim 3. Promote synergies in UM and provide research support/collaborations across Florida, NIH funded
Networks and Programs by: a) Interaction with Cores, Scientific Areas of Interest (SIG), Scientific Working
Groups (SWG) and CFAR membership at large, through participation in group discussions/meetings,
collaborative research projects with clinical/biobehavioral science investigators; b) Advancing the CFAR
laboratory expertise through leveraging non-CFAR resources and inter-CFAR interactions, and c) Responding
to emergent institutional and societal priorities such as COVID-19 for laboratory support, and to develop
techniques to promote research in COVID as it affects HIV; d) Offer CFAR expertise to support HIV Network
activities and HIV research outside UM. Aim 4. Develop and abide by policies and procedures for the Core in
compliance with Core A directives and guidance.